A role for cardiomyocyte pannexin 1 in non-ischemic heart failure

Project Summary
Cardiac fibrosis is currently untargeted in many cardiac disease settings, yet this is a hallmark of
decreased myocardial compliance. Current therapy for patients with heart failure, which has a hallmark of cardiac
fibrosis, includes spironolactone, a pannexin 1 (Panx1) channel inhibitor. Despite this, the role for Panx1 in
cardiomyocytes in non-ischemic heart failure has not been studied. Additionally, Panx1 plays a role in fibrosis in
other diseases, and it has been shown to play roles in inflammation, blood pressure regulation, and myocardial
infarction. Furthermore, it can be activated by G-protein subunits during alpha1D and β3-adrenergic stimulation.
This evidence provides reason to hypothesize that protection from cardiac dysfunction and decreases
pathophysiology including immune cell recruitment and cardiac fibrosis are Panx1 dependent.
Preliminary data in a model of non-ischemic heart failure, 14 days of isoproterenol (ISO) injections, shows
that male mice of a novel mouse with cardiomyocyte-specific pannexin 1 deletion (Panx1MyHC6) are protected
from cardiac hypertrophy and increases in left ventricle volume compared to their Panx1fl/fl counterparts.
Additionally, H9c2 cells, a rat myoblast cell line, with a siRNA-mediated knock-down of Panx1 have blunted
release of ATP compared to control after β-adrenergic stimulation with ISO. This data and other preliminary
studies lead me to address the hypothesis in two aims. In subaim 1A, I will investigate the mechanism of Panx1
activation by β-adrenergic stimulation in cardiomyocytes. I will first determine the mechanism by which ISO
activates Panx1 using established Panx1 mutants in Panx1-null H9c2 cells. I hypothesize that the regulation
occurs via binding of the G-protein βγ-subunits to Panx1 and have a proposed binding site identified from
previous work. I will evaluate this binding site using BioID. In subaim 1B, I will investigate the role of Panx1
channel activation by β-adrenergic stimulation in whole hearts. In subaim 1B, I will perform pressurized
contractile studies ex vivo on Langendorff perfused murine hearts to evaluate Panx1’s effect on cardiac
contraction. For subaim 1B, I will use our novel Panx1MyHC6 mouse. I will test the role of Panx1 in the induction
of cardiac dysfunction in non-ischemic heart failure, using a model of ISO administration for 14 days. Finally, in
subaim 2B I will investigate the role of Panx1 in the progression of non-ischemic heart failure. For this aim, I
will use another novel mouse model which has inducible deletion of Panx1 under the Tnnt2 promoter. I will use
ISO in an osmotic pump for 28 days to induce heart failure and intervene by deleting Panx1 to delineate the role
of Panx1 in the onset versus the progression of non-ischemic heart failure. Both aims will evaluate cardiac
function using echocardiography with Dr. Wolf. I will use histological analysis for fibrotic content and immune cell
infiltration of the myocardium, measure plasma lactate and creatinine as markers of secondary organ damage,
and radiotelemetry for blood pressure changes. Together these studies will identify Panx1 as a novel therapeutic
target and elucidate whether Panx1 channel activation plays a differential role in heart failure disease states.

Public health relevance
Project Narrative While it is considered front line therapy, via spironolactone, to target pannexin 1 for patients with heart failure, it has not yet been explored as a target in the role of cardiac fibrosis and immune cell infiltration in non-ischemic heart failure. The proposed work will test the hypothesis that protection from cardiac dysfunction and cardiac is dependent on pannexin 1 in cardiomyocytes in an isoproterenol administration model of non-ischemic heart failure. By elucidating the role that pannexin 1 in cardiomyocytes plays in cardiac function, immune cell infiltration, and cardiac fibrosis, this proposal will identify a novel therapeutic target.